Genetic Determinants of Tumor Growth and Drug Sensitivity in EGFR Mutant Lung Cancer

PROJECT SUMMARY
The discovery of mutations in EGFR that drive lung cancer growth and confer sensitivity to tyrosine kinase
inhibitors (TKIs) has transformed the treatment of lung cancer. However, responses to TKIs are variable and
resistance ultimately develops. Thus, EGFR-driven lung cancers still cause ~20,000 deaths annually in the US.
These tumors have frequent alterations in diverse tumor suppressor genes (TSGs), however which of these
alterations co-operate to drive tumor growth, how they impact cancer cell state, and whether they are key
determinants of responses to therapy remains largely unknown. Current methods to uncover relationships
between EGFR and TSGs largely rely on correlative human genomic studies and cell line-based models.
However, genomic studies are often statistically underpowered to uncover genetic interactions and do not
provide information on TSG function. Conversely, cell line studies do not recapitulate the in vivo environment
and the limited cell lines that exist represent only a subset of EGFR mutant tumors. To overcome these limitations
and better understand the genomic drivers of lung cancer growth and drug responses in vivo, we recently
integrated a novel autochthonous mouse model of oncogenic EGFR-driven lung cancer with CRISPR/Cas9-
mediated somatic genome editing and high-throughput tumor barcode sequencing. Using this multiplexed in vivo
model, we uncovered the splicing factor RBM10 as a poorly characterized suppressor of tumor growth and
unexpectedly found that inactivation of the “tumor suppressor” Lkb1 is synthetic lethal with oncogenic EGFR.
Here, we will investigate how genotype controls the biology of oncogenic EGFR-driven lung cancer. Specifically,
we will establish the cellular and molecular consequences of Rbm10 inactivation and elucidate the mechanism
that underlies the synthetic lethality between EGFR and Lkb1. Moreover, understanding how tumor genotype
influences treatment responses could reveal genotype-specific therapeutic vulnerabilities. Thus, we will leverage
our multiplexed in vivo gene editing platform to determine the impact of additional TSGs on EGFR mutant lung
cancer growth and uncover genomic drivers of responses to therapy. This work will increase our fundamental
understanding of the genomic determinants of EGFR mutant lung cancer growth and reveal novel and
therapeutically targetable pro-tumorigenic pathways. These findings could ultimately inform precision treatments
for patients with oncogenic EGFR-driven lung cancer.

Public health relevance
PROJECT NARRATIVE Over the past ~15 years there has been tremendous progress in the treatment of lung cancer with EGFR mutations with targeted therapies. However, even the newest agents are not curative and there is variability in the depth and durability of responses. The goal of this research is to provide insight into the genetic mechanisms that modulate the growth and sensitivity to therapy of EGFR mutant lung tumors to eventually identify better potential therapeutic strategies for this disease.